Admin Core

PROJECT SUMMARY
The objective of the Center for Lung Biology and Disease (aka Lung COBRE) at Louisiana State University
(LSU) is to elucidate the molecular and cellular pathogenesis of life-threatening acute and chronic respiratory
diseases affecting human population. The Administrative Core (AC) will provide administrative support,
organization, coordination, and efficient management necessary to ensure the success of the lung COBRE and
of our Promising Junior Investigators (PJIs). This Core will also provide accounting support that will ensure
appropriate fiscal and scientific oversight, monitoring, and compliance with federal and institutional grant
management regulations. The COBRE will be administered within Pathobiological Sciences (PBS) in
collaboration with Comparative Biomedical Sciences (CBS) in the LSU School of Veterinary Medicine (LSU
SVM). In the current funding climate, success for the lung COBRE depends on numerous factors: 1) an
outstanding personalized mentoring program; 2) renovated animal holding and research space with state-of-
the-art facilities; 3) access to modern equipment and cutting-edge technology through Scientific Cores; 4)
remove excessive administrative and service burdens for PJIs; and 5) foster collaborations within the institution
and between institutions in Louisiana through NIGMS-funded INBRE, COBRE and LA CaTS. To promote the
career development of PJIs, we have assembled senior scientists with outstanding track record to serve on
Internal (IAC) and external advisory (EAC) as well as mentoring committees (MC). The PJI’s individual projects
will be supported by Pulmonary Immunopathology (PIP) and Molecular Biology (MB) cores to leverage
excellent local strengths in biomedical research. To ensure success of the lung COBRE, we have developed a
15-year strategic plan to establish (Phase I - 5 years), expand (Phase II - 5 years), and sustain (Phase III - 5
years) lung COBRE to become an independent center and to attain national and international recognition
through multiple sources of funding, such as federal, state, foundations, industry, and university.

Public health relevance
NARRATIVE The objective of the Center for Lung Biology and Disease (aka Lung COBRE) at Louisiana State University (LSU) is to elucidate the molecular and cellular pathogenesis of life-threatening respiratory diseases, such as tuberculosis, influenza, allergic asthma, and acute lung injury. The overall objective of the Administrative Core (AC) is to provide a strong mentoring environment and centralized infrastructure support via scientific cores to ensure the successful transition of Promising Junior Investigators (PJIs) to become independently funded. The specific aims of the AC are: 1. To provide fiscal and administrative support for projects and scientific cores and implement regular outcome evaluations, 2. To provide fiscal and administrative support for projects and scientific cores and implement regular outcome evaluations, and 3. To coordinate interactions between the lung COBRE and wider scientific community.